CD4+ T-LYMPHOCYTE RESPONSE TO HIV ENVELOPE PROTEIN

To measure the alteration of codon 215 of reverse transcriptase prior to increase in viral load and measure the efficacy of ZDV,ddl,NVP combination antiretroviral therapy.